18th Northwest Reproductive Sciences Symposium (NWRSS)

PROJECT SUMMARY
In May 2022, the 18th Northwest Reproductive Science Symposium (NWRSS) meeting will be hosted by
the Center for Reproductive Biology (CRB) in Cle Elum, WA. The meeting will return to the Suncadia Lodge,
the venue for the successful 2014 NWRSS meeting. This long-standing series began in 1989 as the
Washington State University (WSU) and the University of Idaho (UI) annual joint minisymposium, but now
rotates biennially between WSU/UI, Oregon State University (OSU), and the Oregon Health Sciences
University (OHSU). The scientific program serves to showcase the high quality of regional research in
reproductive sciences, fertility and contraception, developmental biology, and animal and human health. The
objective of the NWRSS meeting is to promote the exchange of information to advance our collective
understanding of the mammalian reproductive tract both in normal function and in diseased states. Because
most of the attendees are concentrated in the Pacific Northwest, many lasting collaborations arise from these
gatherings that have proven both productive and easy to maintain. The NWRSS meeting seeks to support
career development within all aspects of reproductive biology, enabling interaction between trainees, new
investigators, and established principal investigators. The training aspect of the NWRSS extends to the
organization of the meeting as well, as the trainee program committee is solely responsible for organizing the
scientific sessions into thematic groups, selection of trainee platform speakers, and service as session chairs.
The majority of the NWRSS talks are delivered by post-doctoral fellows and students. This year, in addition to
Keynote address from a preeminent leader in the field of reproductive biology, speakers addressing health
disparities in reproduction and diversity in STEM fields will be featured in the program. The organizers and
participants of the NWRSS are committed to providing a safe and inclusive environment to foster the sharing of
ideas between developmental biologists, molecular biologists, systems biologists, population health biologists,
and clinicians working in the field of reproductive biology.

Public health relevance
PROJECT NARRATIVE The goal of the Northwest Reproductive Sciences Symposium (NWRSS) series is to promote the productive exchange of ideas and foster an environment in which trainees, early-stage investigators, and senior scientists can share their work and develop lasting collaborations. To this end, since its inception in 1999, 71% of NWRSS participants have been trainees or junior scientists, >60% women, and ~25% underrepresented minorities. The NWRSS is committed to fostering a diverse and inclusive environment which makes a significant impact on the training of young investigators to advance reproductive science and bring fresh ideas to translational research involving reproductive biology.